Integrated pathogenicity assessment of clinically actionable genetic variants

Integrated pathogenicity assessment of clinically actionable genetic variants
!
Project Summary/Abstract
Large biobanks such as All of Us and the Million Veteran Project have now collected genetic data from
millions of patients, and other population health studies are expanding rapidly. The interpretation of variants in
clinically actionable disease genes is becoming increasingly common in such projects. The American College
of Medical Genetics and Genomics has recommended that sequence interpretation include a minimum set of
59 genes regardless of the indication for sequencing (ACMG 59). These genes are responsible for a variety of
clinical syndromes and have been extensively studied. However, even in well-studied disease genes, the
majority of variants are only observed in one or two families. which makes it challenging to be sure of their role
in causation of disease. Further, while there may be existing evidence about a variant, it is often inadequate for
interpretation, as many variants in databases were originally identified in small, symptomatic cohorts without
matched control groups, so their associations can suffer from incorrect estimates of significance or effect size,
and a non-trivial fraction are likely to be spurious.
For these reasons, a central challenge in clinical genomics is to interpret variants in clinically actionable
genes that are identified during sequencing. Because the ACMG 59 genes have been studied intensively due
to their clinical applicability, there is a unique abundance of functional and structural data that can be used to
improve predictions. Here, we propose to develop new data that can be leveraged in the clinical assessment of
variants including novel predictions of structural consequences, regional and structurally-informed selective
constraint, and clinical risk from clinical diagnostic and epidemiologic health data. Using these data, we will
develop a Bayesian statistical model to predict the effects of mutations that can complement existing
assessments made by consortia and clinical laboratories.
This will specifically include efforts to intensively improve computational predictions of structural and
functional impact using the extensive scientific and medical knowledge in each of these genes. Next, we
combine that structural and functional insight with large-scale population data. We will measure statistical
aberration of variation for related groups of missense variants, and also identify groups of variant sites which
are enriched in recurrent somatic or germline variation associated with cancer. Finally, we will develop a
Bayesian prediction framework that integrates the full set of variant observations and characteristics to improve
predictions of clinical risk for individual variants, and prospectively measure its performance in a clinical
diagnostic laboratory. !
!

Public health relevance
Integrated pathogenicity assessment of clinically actionable genetic variants ! Project Narrative The interpretation of variants in clinically actionable disease genes (e.g. ACMG 59) is increasingly common in biobanks and large population health studies. Even in well-studied disease genes, the majority of variants are only observed in one or two families, which makes interpretation of these variants challenging. We propose to leverage the large amount of structural, biochemical, and clinical data available about these genes to dramatically improve computational assessments of these variants. !